Indigenous linguistic and cultural concepts of heritability and comprehension of

DESCRIPTION (provided by applicant): The Indigenous linguistic and cultural concepts of heritability and comprehension of genomics research in Nigeria (INDIGENE) study is a project designed to evaluate the use of linguistic and culturally derived concepts of genomics and heritability in an indigenous African population and use this to develop enhanced consent forms. The project will then test the impact of these enhanced consent forms on the comprehension of genomics research, diabetes mellitus and principles of informed consent within the context of an H3Africa Diabetes Mellitus Genomics research project in Nigeria. The impact of the enhanced form on participants' comprehension and satisfaction will also be evaluated

Public health relevance
PUBLIC HEALTH RELEVANCE: Indigenous linguistic and cultural concepts of heritability and comprehension of genomics research in Africa (INDIGENE) study is a study of the impact of using enhanced consent forms on the comprehension of informed consent in genomics research of diabetes mellitus